Admin Module

Administrative Module
Abstract
The functions of Administrative Core Component are to provide strategic supervision to the core facilities for
vision research at Duke University and to oversee the routine operation of four resource Modules supported by
this grant. All major decisions regarding the scope of services supported by this grant and investments in new
technologies and methodologies will be made by the Core Grant Advisory Committee, which includes the PI,
the Module Directors, and rotating NEI-funded investigators. Periodic (usually biannually) meetings of this
Committee are typically open to the entire community of visual scientists and used as forums to discuss core
usage and optimization, pressing needs and future plans. The daily operation of service Modules will be
conducted by highly skilled personnel reporting to Module Directors. The accounting and financial reporting for
this grant will be performed by the Office of Grants Administration. This office will provide monthly account
statements to the PI, who will discuss them with Module Directors. In addition to open meetings of the Core
Grant Advisory Committee, communication with members of the vision science community will be conducted
through periodic emails summarizing major technical developments, equipment repairs and updates, and
introduction of new commonly used services.